COMPASSIONATE USE OF THE GCRC TO CONDUCT STUDIES ON SINGLE PATIENT WITH LIPOMA

The purpose of this single patient compassionate use of the GCRC was to perform metabolic and tissue studies on a patient with a large lipoma.